NEW MODALITIES FOR ACTIVE IMMUNOTHERAPY OF MALIGNANCIES

Research described in application will take advantage of recent conceptual developments in the mechanism(s) of cellular immune recognition to devise novel modalities of immunotherapy for immunoglobulin (Ig)-expressing B cell malignancies. B cell malignancies express tissue-specific differentiation antigens that, as is the case for Ig, may have B cell- subset-specific or tumor cell-specific antigenic determinants that are clonally distributed. Development of strategies that either enhance cellular immune recognition of tumor-specific Ig and/or break self- tolerance to B cell-subset-specific Ig antigenic determinants may have immunotherapeutic applications that transcend those applicable only for B cell tumors. To this end, we will: 1) examine the immunotherapeutic utility of in vivo transient transfection of somatic cells using DNA vaccines encoding Ig V genes or Ig V gene fragments with or without appended signal sequences of genes encoding accessory cytokines, such as IL-2 or IL-4; 2) evaluate human lymphoblastoid cell lines transfected with such Ig-encoding DNA vaccines for their capacity to stimulate syngeneic Ig V gene-directed cytolytic T cells lines (CTL) in vitro; 3) investigate modalities of active immunotherapy for a transplantable murine B cell hybridoma expressing rheumatoid factor (RF) encoded by murine Ig variable region genes (V genes) that have not diversified substantially from the germline DNA; 4) evaluate the short and long-term effects on transgene expression of active Ig-directed immunotherapy in mice transgenic for human IgM RFs; and 5) clinically investigate the in vivo immunogenicity of transfectoma-derived IgM for B cell leukemia populations expressing Ig with shared cross reactive idiotypic determinants. Through these studies we may develop novel and clinically effective active immunotherapeutic regimens for human neoplasia.